The MusicGens Consortium: Growing robust and rigorous approaches to musicality genomics

Project summary.
The etiology and effects of musicality, broadly defined as the set of fundamental human
capacities to interact with music, have mainly been studied via brain and behavioral methods
and primarily at small scale, until very recently. We formally established the Musicality
Genomics Consortium (MusicGens) in 2022 as an international network of researchers
dedicated to the advancement of research on the genomics of human musicality traits via multi-
site, cross-disciplinary collaboration. The purpose of MusicGens is to enable scientific
discoveries related to the genetics, genomics and phenomics of musicality, by fostering
research directions of a large magnitude that would not be possible for any single research
group to pursue alone. The overarching objective of this grant is to provide a stable forum to
nurture a robust and rigorous science of musicality genetics via conference support for the
annual meeting of MusicGens. The conference funding will support the educational and
research missions of the annual meeting, with specific resources dedicated to expanding
participation to a more diverse range of individuals and to developing strategies for augmenting
musicality genomics research in populations underrepresented in biomedical research. The
conference support has the potential for impact in the arena of multiple basic science and
translational manifestations of how and why musicality unfolds over the lifespan, with
particularly innovative potential for precision health.

Public health relevance
Public Health Narrative This project brings together world experts in complex traits genetics and music cognition to understand how DNA variation relates to many aspects of human musicality. By providing support for the annual meeting of the Musicality Genomics Consortium, we provide an important intellectual resource for this emerging field. Research findings may reveal new clinical- translational applications that could emerge from new knowledge of how and why human musicality unfolds over the lifespan.